Disruption of neuromodulatory signaling in models of Alzheimer's Disease

PROJECT SUMMARY:
Degeneration of neuromodulatory neurons, such as cholinergic neurons in the basal forebrain and
noradrenergic neurons in the Locus Coeruleus, is a key hallmark of advanced Alzheimer’s Disease (AD). Loss
of neuromodulatory inputs to the cerebral cortex contributes to dysregulation of attention, arousal, and
cognition, processes that are robustly modulated by release of acetylcholine (ACh) and norepinephrine (NE).
Functional dysregulation of these neuromodulatory systems likely precedes late-stage loss of projection
neurons and contributes to early cognitive symptoms. However, despite extensive anatomical evidence, there
is little functional data on neuromodulatory signaling across stages of pathology. In addition, technical
limitations have precluded longitudinal measurements of neuromodulatory signaling in genetic models of
disease. To address this gap, we propose to combine novel imaging approaches, including wide-field
‘mesoscopic’ imaging of ACh and NE signaling and neuronal activity across the entire cortex in awake
behaving animals. Using two genetic models of AD, we will test the following hypotheses: (1) The initial
consequence of pathology is early loss of state-dependent spatiotemporal dynamics of ACh and NE signaling.
(2) AD pathology causes a progressive loss of coupling between neuromodulators and cortical activity and
between ACh and NE. Importantly, we will longitudinally track changes over time within each animal and also
compare across models to identify convergent signatures of disease-related dysregulation. Our results will
provide an unprecedented level of insight into the disruption of key neuromodulatory systems throughout the
lifetime in models of Alzheimer’s Disease and provide a novel framework for future evaluation of therapeutic
approaches.

Public health relevance
PROJECT NARRATIVE: Degeneration of neuromodulatory projection neurons, the cholinergic and noradrenergic neurons that project to the cerebral cortex, is a key hallmark of advanced Alzheimer’s Disease, but little is known about neuromodulatory disruption in early disease stages. This proposal will use novel imaging techniques to determine how cholinergic and noradrenergic dysregulation progresses across the lifespan in mouse models of Alzheimer’s Disease. We expect our findings to provide important insights into the role for neuromodulatory dysregulation in Alzheimer’s and to form a framework for future testing of therapeutic approaches.